Automated Multiplex Analyzer for Sepsis and Beyond

Project Summary/Abstract
The current paradigm of monitoring various blood parameters in critical care are manual, labor intensive,
infrequent, and prone to inaccuracies while wasting so much blood as to cause anemia in patients with prolonged
ICU stays. There is a well-established clinical need for frequent monitoring of blood parameters in critical care
settings to support early identification and therapeutic management for a range of conditions such as sepsis,
shock, acidosis, uncontrolled glycemia, and traumatic injuries. For instance, early diagnosis and management of
sepsis and acidosis, through timely lactate measurements supported by additional parameters like glucose and
hematocrit enables rapid intervention that reduces mortality. Appropriately timed glucose measurements are
essential for achieving tight glycemic control in critical care settings, while frequent hematocrit monitoring
guides transfusion therapy for patients with traumatic injuries. Through an NIH SBIR Phase I award, Cascade
Metrix (CMX) developed and validated a patient-connected automated multiplex analyzer (AutoPlexer) whose
initial embodiment provides pre-programmed or on-demand measurement of lactate, glucose and hematocrit in
whole blood using a central venous catheter. The AutoPlexer’s automated blood sampling and measurement
performance was validated in preclinical studies using porcine models. Notably, no blood is lost by the subject,
nor is there a need to infuse anticoagulants such as heparin. The automation and trending information provided
by the AutoPlexer’s simultaneous measurement of multiple analytes is expected to significantly improve patient
outcomes by enabling both early diagnosis and precise ongoing therapeutic management. In this Phase II project,
the current AutoPlexer basic platform will be refined and validated for first-in-human studies and its
measurement capabilities will be expanded to include additional parameters to enhance market traction
following the introduction of the 3-analyte version. These parameters include: venous oxygen saturation,
creatinine, plasma volume status, pH, pyruvate, glutamine, as well as other biomarkers.
Ultimately, the AutoPlexer will stream its measurement data into AI/ML and workflow tools that support
glycemic control, sepsis management and the like. SBIR Phase II funding will be combined with private equity
funding to obtain FDA 510k regulatory approval and launch of the 3-analyte AutoPlexer for early adoption in
critical care. As further sensor technologies are developed and incorporated into the AutoPlexer platform, FDA
approval will be sought using the 3-analyte system as the predicate. The introduction of these analytes and any
newly emerging biomarkers into the measurement suite of AutoPlexer will deepen coverage of wide-ranging
acute pathologies encountered in critical care and enhance traction.

Public health relevance
Project Narrative Timely diagnosis and monitoring of ongoing therapy for sepsis and other critical care conditions is associated with significantly better clinical outcomes and lower health care costs. Achieving this demands efficient, timely, safe, and accurate analysis of multiple vital blood parameters. The proposed effort is geared towards the development and clinical validation of a patient-connected automated multiplex analyzer that measures lactate, glucose and hematocrit to begin with, but will be expanded to measure a range of other analytes of proven clinical value in critical care settings.